Project 3: Targeted therapy for splicing factor mutant myeloid malignancies

Current therapies for myelodysplastic syndromes (MDS) are unsatisfactory. We and others discovered splicing
factor mutations in patients with MDS and acute myeloid leukemia (AML) and reported that expression of
mutant splicing factors increase the abundance of R loops, which are structures containing DNA:RNA hybrids
and displaced single-strand DNA. R loops trigger an ATR-dependent DNA damage checkpoint response that
mediates resolution of the R loop to protect cells from genomic instability and cell death. In a phase II trial we
observed activity of Ceralasertib (AZD6738) monotherapy, an oral ATR inhibitor (ATRi), in adult patients with
MDS who relapsed or were refractory to front-line therapy, but combination therapy will be required for more
durable clinical benefit. We recently discovered that splicing factor mutations also activate PARP1 through an
R loop-dependent mechanism, rendering cells sensitive to PARP inhibition. Dual inhibition of ATR and PARP
(PARPi) are synergistic in preclinical models in vitro, suggesting that pathways converging on R loop regulation
may provide a mechanistic approach to target these malignancies. We hypothesize that splicing factor mutant
myeloid malignancies are vulnerable to dual inhibition of the ATR and PARP pathways. In Specific Aim 1, we
will optimize the combination of ATR and PARP1 inhibition using preclinical models of myeloid malignancies
with spliceosome mutations. We will use multiple pre-clinical models to test the tolerability and efficacy of ATRi,
PARP1i, and the combination in vivo: 1) mutant U2af1 and Srsf2 mouse AML models in congenic recipients, 2)
xenografted gene-edited human cell lines labeled with luciferase, and 3) primary human MDS/AML xenografts.
Our goal is to conduct a phase II trial of ATRi + PARP1i in patients with splicing factor mutant
relapsed/refractory MDS based on our findings. As an alternative approach, we propose to inhibit CHK1 (a
downstream target of ATR) using a novel agent with minimal hematologic toxicity. In Specific Aim 2, we will
determine the mechanisms of sensitivity and resistance to ATR inhibition in myeloid malignancies with and
without splicing factor mutations. We developed independent lines of evidence suggesting that loss-of-function
mutations in RUNX1 are associated with resistance to DNA damage response inhibitors, including ATRi, in
splicing factor mutant cells. We hypothesize that transcriptional changes induced by RUNX1 loss confer
resistance to ATRi by altering R loop metabolism or other mechanisms. We will use a genetically-defined
preclinical model to test the impact of RUNX1 loss on ATRi resistance and identify putative mechanisms of
resistance. We also observed that splicing factor wild-type patients with co-mutations in DNMT3A/ETV6/del7
are sensitive to ATRi. We hypothesize that these mutations confer sensitivity to ATR inhibition by inducing
replication stress, phenocopying splicing factor mutations. We will assess biomarkers of replication stress in
primary human MDS/AML samples. Collectively, this project will nominate combination therapies to develop
the first novel:novel combination of drugs to treat MDS and AML with splicing factor mutations.

Public health relevance
We and others discovered that RNA splicing factors are mutated in the blood cells of many patients with myelodysplastic syndromes (MDS) and acute myeloid leukemia (AML), leading to the formation of DNA:RNA hybrids in cells (i.e., R loops) and activation of ATR and PARP1 DNA damage response pathways. Inhibition of ATR or PARP cause splicing factor mutant cells to die and the combination is synergistic. This project will optimize the combination of ATR and PARP1 inhibition in preclinical models, providing the rationale for an investigator-initiated clinical trial.